Structural and functional characterization of natural killer cell receptors

The function of natural killer (NK) and myeloid cells depends on the balance of a number of activating and inhibitory receptors. Natural cytotoxicity receptors (NCR) are the major receptors responsible for NK cell-mediated lysis of tumor and viral-infected cells. In the past few years, we have characterized the structure and function of several inhibitory as well as activating NK cell receptors. These include the crystal structures of CD94, KIR2DL2 and its complex with HLA-Cw3, NKG2D and its complex with ULBP3, NKp46 and TREM-1. Despite the progress made in understanding the function of NK receptors in the past few years, the ligands recognized by NCR remain unknown. Our effort of understanding the function of NCR has led a structural solution for NKp30. The structure revealed striking resemblence between NKp30 and CTLA-4 family receptors and enabled us to propose a potential ligand binding site.The ability of NK cells to distinguish self versus non-self cells is particularly critical in tissue transplantation and tumor rejection.UL16 binding proteins (ULBPs) are a family of cell surface proteins present in transformed and stressed cells and ligands for NKG2D. Soluble NKG2D ligands have been found in sera from cancer patients with their protein concentrations correlated with poor cancer prognosis. Here we show that human tumor cells lost their surface ULBP2, but not ULBP1 and ULBP3 expressions during NK-mediated cytolysis. The shedding of ULBP2 was induced by target cell apoptosis and a result of metalloproteinase cleavage. Inhibition of ULBP2 shedding by a metalloproteinase inhibitor BB-94 resulted in down-regulations of NKG2D expression and cytokine production on NK cells. Thus, the NKG2D ligand shedding enables NK cells to optimize their function by selectively engaging live target cells. This may be a mechanism for NK cells to distinguish live versus killed cells. In collaboration with Dr. Alfred Singer's group at NCI, we investigated the determinants for T cell receptor specificity against MHC ligands. The central feature of T cell biology is that αβ T cells selected from the thymus utilize their antigen receptors (αβTCR) to specifically recognize antigenic peptides presented by the major histocompatibility complex (MHC), a characteristic referred to as MHC-restriction. However, the mechanisms leading to MHC-restriction of αβ T cells are not fully understood. Previous structural studies of αβTCR and peptide/MHC complexes suggested that MHC-restriction is intrinsic to αβ TCR structures as a result of germline-encoded CDR1 and CDR2 loops that have evolved to specifically promote contacts with MHC. In contrast, emerging evidence has shown that MHC-restriction is imposed by thymic selection in that coreceptor-independent TCR signaling in the thymus permits selection of αβTCRs that recognize MHC-independent ligands. We determined the structures of two MHC-independent αβTCR (A11 and B12A) both recognizing mPVR as their activation and selection ligand. B12A and A11 closely resemble the conventional MHC-restricted αβTCRs, demonstrating the structures of germline V genes could not pre-determine αβTCR ligand specificity. Further deep sequencing analysis revealed that the overall germline Vβ gene usage was similar in the peripheral αβTCR repertoire of both wild type B6 and Quad_KO mice. Nevertheless, individual αβTCR clones were selected at remarkably different frequencies in the presence or absence of MHC, further demonstrating the ligand specificity of αβTCRs was imposed by the thymic selection. Moreover, B12A and A11 αβTCRs recognized different epitopes on mPVR, reminiscent of antibody-antigen recognition. In summary, our results suggest that within the pre-selected repertoire αβTCRs are capable of recognizing a huge diversity of ligand structures and highlight the role of thymic selection in determining the αβ TCR specificities.